Natural Killer Cell Subpopulations in COPD Exacerbations

Despite decades of research, no effective therapies exist to circumvent the irreversible alterations in
lung function associated with COPD. Further, complications of COPD arise from acute and chronic
exacerbations that amplify ongoing injury and remodeling that increase morbidity and mortality. The
pathophysiology of exacerbations is poorly understood, but is primarily due to inflammation from infections.
Some patients are more susceptible to exacerbations and represent an `exacerbator phenotype' associated
with COPD-dependent changes in innate and adaptive immunity. Natural killer (NK) cells are a
heterogeneous population of lymphocytes that are important in the defense against infections. They are also
involved in initiating and directing active immune responses through cytokine production. NK cells recognize
pathogen-infected cells expressing ligands for an array of activating and inhibitory receptors. Research by
our lab and others identified multiple effects of smoking on NK cell function that suggest these changes are
significant in the pathophysiology of COPD exacerbations. Traditionally, NK cells were divided into immature
and mature subpopulations based on CD16 and CD56 expression. Recently, high-dimensional analysis of
NK cells revealed a surprisingly high degree of phenotypic diversity and that each individual has thousands
of unique populations of NK cells. Although the expression of various NK cell surface markers provides clues
about the function of subpopulations, the significance of each populations is unknown. Therefore, we probed
NK cell phenotypes from a cohort of non-smokers, smokers, and COPD patients targeting NK cell activating
and inhibitory receptors. These studies revealed several unique NK cell populations that differed between
groups. Further analyses showed that the size of NK cell subsets associated with a previous exacerbation
with 95% confidence. Based on these findings, we hypothesized that smoking alters NK cell heterogeneity
which leads to the emergence of unique populations that can serve as biomarkers of increased risk of COPD
exacerbations. We will test this hypothesis with the following Specific Aims: Aim 1: Define the natural history
of NK cell diversity and plasticity in never smokers and smokers. Previous analyses of NK cell populations
over time are based on limited phenotyping and high-dimensional analyses of NK cell populations have been
derived from a single time point. To advance our understanding of the heterogeneity of NK cell populations
over time, we will conduct a 3-year prospective longitudinal analysis of NK cell plasticity in never smokers
and current smokers without COPD. Aim 2. Define whether alterations in NK cell populations precede or
occur following exacerbations in COPD to determine the usefulness of NK cell phenotyping as a biomarker
of future exacerbations. Preliminary data identify alterations in NK cell subsets associated with COPD
exacerbations. However, we do not know if these alterations precede and predict future COPD exacerbations
or if they arise as a consequence of exacerbations. Further, if COPD exacerbations trigger changes in NK
cell populations, it is not known if these derangements persist finitely or indefinitely. Aim 3. Define the
functional significance of unique NK cell populations associated with COPD exacerbations. We show that
only 15-30% of bulk NK cells respond to cytokine stimulation to elaborate proinflammatory cytokines. This
indicates that a specific subpopulation(s) is uniquely capable of generating a response. NK cells have
obvious importance in immune homeostasis. Therefore, future treatment options for COPD exacerbations
require a balanced approach reflecting the need to preserve/restore necessary effector functions without
disarming or overstimulating the entirety of the NK cells. This Aim will provide a critical advance in our
understanding of the functional heterogeneity of NK cells in COPD and reveal insight into the significance of
the NK cell subpopulations associated with COPD exacerbations.

Public health relevance
The research is relevant to the VA because it addresses a common incurable disease, chronic obstructive pulmonary disease (COPD), which afflicts as many as forty percent of the veteran population. COPD is an incurable disease punctuated by disease exacerbations, usually attributed to infectious insults, which accelerate morbidity and mortality. This project examines the plasticity of immune cell populations that we show predict COPD exacerbations. The research will perform longitudinal studies in COPD patients to define the natural history of natural killer cell plasticity and function and examine the effects of smoking and other disease co-variables in the susceptibility to exacerbations. The successful completion of this project is expected to lead to novel insight and discoveries that will better inform clinicians in the treatment of COPD patients. This contribution would decrease the morbidity and mortality, and enhance the quality of life in COPD patients.